Regulation of Vascular Smooth Muscle Cell Phenotype by a Novel Isoform of Glucose-6-Phosphate Dehydrogenase

Vascular diseases continue to be a major cause of death in the US and worldwide. It has been proposed that metabolic
reprogramming and increased glucose-6-phosphate dehydrogenase (G6PD) activity and expression contribute to the
pathogenesis of fatal angioproliferative vasculopathies. Moreover, some studies suggest individuals with a loss-of-
function G6PD (Mediterranean or African) variant – S188F (G6PDS188F; Type A-; severe deficiency) or N126D
(G6PDN126D; Type A; mild deficiency) nonsynonymous single nucleotide polymorphism – have lower frequencies of
coronary artery disease. However, G6PD-driven pathogenic and G6PD variant-associated protective mechanisms
affecting vascular diseases remain elusive. We therefore propose to determine potential mechanisms, driven by a newly
discovered G6PD isoform in the nucleus of vascular smooth muscle cells (VSMCs), that contribute to pathogenic large
artery stiffness and remodeling. Based on strongly supporting preliminary results, we hypothesized that nuclear G6PD
is a modulator of epigenetic modifiers and is a transcription regulator in VSMCs. Consequently, the loss-of-function
G6PD (S188F, N126D) variants block maladaptive modifications of the epigenome, reducing large artery elastance and
remodeling elicited by obesity/metabolic syndrome and balloon-injury. We will test this hypothesis in three specific
aims. In Aim 1, we will test the hypothesis that G6PD and/or G6PD-coordinated redox in the nucleus controls the
expression and activity of epigenetic modifiers (DNA methyltransferases (DNMT) and DNA (TET) and histone
(JARID) demethylases) and transcription of genes that encode proteins involved in regulating the differentiation
(contractile) and dedifferentiation (pro-inflammatory, -thrombotic, and -proliferative) phenotypes in VSMCs. In Aim 2,
we will determine whether loss-of-function G6PD variants detach from epigenetic modifiers to increase DNA
methylation, suppress histone3-lysine4 trimethylation, and reduce transcription of genes that confer maladaptive (pro-
inflammatory, -thrombotic, and -proliferative) properties to VSMCs. In Aim 3, we will determine whether G6PD variant
rats express fewer maladaptive epigenetic (histone3-lysine4 trimethylation) changes and develop less large artery
elastance (stiffness) and vascular remodeling than wild-type rats fed a high-fat diet (a model of obesity/metabolic
syndrome) or subjected to carotid artery balloon-injury. The results from gain-of-function and loss-of-function studies
of this project will reveal the direct effect of G6PD on gene expression associated with pathogenic vascular remodeling
and large artery stiffness, which lead to heart failure and death. We foresee two significant impacts on vascular biology:
[1] linkage of heretofore unknown G6PD-dependent subcellular redox in the nucleus directly to the fundamental
transcriptional mechanics and gene transcription in vascular pathobiology and [2] development of new treatments
targeting redox signaling to reduce large artery stiffness and remodeling.

Public health relevance
Vascular diseases continue to be a major cause of death in the US and worldwide. The focus of this proposal is to determine the contributions of altered metabolism and increased glucose-6-phosphate dehydrogenase (G6PD) activity and expression to the development of deadly vascular diseases. We anticipate the results of this project will reveal the direct linkage between G6PD and expression of genes that contribute to vascular pathology and will further the development of new treatments to reduce vascular diseases.